Genome topology in the filamentous fungus Neurospora crassa: organizing factors and impact on genome function

Project Summary/Abstract
Eukaryotic chromosomes compact into the nucleus while maintaining a precise, non-stochastic organization that
allows genome function, including gene expression and chromatin formation. In humans, genome disorder can
cause to aberrant gene expression and uncontrolled cellular growth, leading to oncogenic tumor formation, as
observed in neuroblastoma and pancreatic cancers. However, a complete understanding of the mechanisms
necessary to organize eukaryotic genomes is not known in any species, which is a critical gap in our collective
knowledge. Specifically, many (epi)genetic factors have not been examined for roles in organizing genomic DNA.
The long-term goal of this project is to elucidate how genome organization is formed in eukaryotic nuclei and
dissect the role of genome organization on transcriptional control. To this end, we will use the innovative fungal
organism Neurospora crassa as a model for human systems, given the similarities of its epigenetic regulation
and extent of DNA compaction with humans; the Neurospora genome is subdivided into active euchromatin and
silent heterochromatin catalyzed by similar proteins. However, the smaller fungal genome allows cost-efficient
genomic studies, and the genetically tractable Neurospora employs simple epigenetic machinery often involving
single protein complexes to allow direct study of individual histone marks. Further, study of a model fungal system
will allow direct comparisons to fungal pathogens of humans, as both have similar genome folding patterns. The
proposed research, building upon previous results, will examine fungal genome organization by chromosome
conformation capture with high-throughput sequencing (Hi-C) in different genetic backgrounds to understand the
(epi)genetic factors organizing the fungal genome and the resulting effects on genome function. Previously, we
showed loss of the HCHC histone deacetylase complex caused hyperacetylation of heterochromatin which
influenced genome organization. First, we will characterize the histone lysines targeted by the HCHC, examine
HCHC deacetylation over the cell cycle, and identify the histone acetyltransferase acetylating heterochromatic
regions. Secondly, given how heterochromatic region bundling is one of the main features of fungal genome
organization, we will determine if the de novo formation H3K9me3 or a protein binding to the underlying AT-rich
DNA is necessary for genome organization; we will also assess if changes to heterochromatin region boundaries
influence genome topology. Lastly, since subtelomere clusters are one of the main features of organizing fungal
chromosomes, we will characterize a telomere-binding protein complex for role(s) in genome organization. The
research for these Specific Aims will be primarily led by undergraduate students, who will directly build strains,
perform genomics experiments (e.g., Hi-C and Chromatin Immunoprecipitation-sequencing), analyze resulting
datasets, and present results in conference presentations and peer-reviewed manuscripts, thereby creating an
outstanding training environment for UCCS students for careers in scientific research or medicine. Together, our
multi-faceted approach will advance our understanding of eukaryotic genome organization and function.

Public health relevance
Project Narrative Genomic DNA is precisely organized in eukaryotic nuclei for proper DNA function - including gene regulation - and cellular growth; if DNA improperly folds, this genome disorder triggers unregulated oncogene expression, which may cause the uncontrolled cellular growth that is a hallmark of cancer. However, little is known about what proteins organize DNA in the nucleus, and this represents a critical gap of knowledge warranting further research. The studies proposed here will characterize how changes to silent genomic regions can alter DNA folding using the model fungal system Neurospora crassa, thereby elucidating human genome organization and providing fundamental knowledge that could allow treatment of pathogenic fungal infections in humans.